Administrative Core

The Johns Hopkins University DELTA Center (Delivery of Early Liver Transplant for Alcoholic
Hepatitis) provides focused and multidisciplinary care to patients with Alcoholic Hepatitis and
rigorously studies these efforts to advance the treatment of this challenging patient population.
The P50 Specialized Alcohol Research Center (SPARC) funding supports four highly
interconnected and integrated research projects together with an Administrative Core (Admin
Core) and a Pathology resource Core (Path Core). The broad goal of this P50 renewal proposal
is to continue to characterize our novel patient cohort on several different levels and offer this
information to the national alcohol research community. In support of this effort, the Admin core
will work with finance managers from the departments of Surgery, Medicine, Pharmacology and
Pathology to set up and manage budgets for each project or core and provide project leaders
with regular financial reports. In addition, the Core will assist investigators in preparation of
manuscripts and competing and non‐competing grant renewals, as well as processing of
resource sharing requests. The Admin Core will collaborate with individual Project Leaders to
help identify and train the next generation of clinical and research leaders for alcoholic hepatitis.
Importantly, the Admin Core will meet regularly with other project leaders to ensure that all
projects comply with IRB, ACUC and other regulatory standards including the ethical conduct of
research. Finally, the Admin Core will coordinate and provide logistical support for monthly
program steering meetings, for invited seminar speakers and for the annual program retreat and
advisory board meeting. The Admin Core will also continue to organize forums for interaction
between our Center and other NIAAA funded alcohol research program including through future
iterations of the Johns Hopkins DELTA Center for Alcohol Research Symposium on Alcoholic
Hepatitis.

Public health relevance
Project Narrative Severe alcoholic hepatitis (SAH), an acute presentation of alcoholic liver disease (ALD), carries an extremely high mortality rate and early liver transplantation (ELT) is the only life-saving option available for patients who are refractory to medical management. We have established the largest cohort of ELT recipients in the world and preliminary investigations have shown promising short-term outcomes for individuals who undergo ELT and given us considerable insight into the pathophysiology of ALD. The insight provided by the studies described in the projects that comprise our ALD research initiative will be integral for guiding the expansion of ELT and the ethical framework developed will help influence the creation of a national policy governing the practice.